Functional and Molecular Dissection of Marmoset Face Areas

PROJECT SUMMARY
Face perception is supported by multiple highly specialized regions, interconnected to form a face-processing
network. Because of the clarity of its functional organization, the system has allowed for unprecedented insights
into the neural mechanisms and computational principles of high-level object recognition at large. These insights
were gained through recordings from face areas that have been blind to the molecular properties of face cells.
Yet the conserved organization of face areas among primates suggest an evolutionary origin in which genetic
alterations may have contributed to circuit-specific innovations in neuronal properties that endowed these areas
with their function. Genes expression patterns differentiate one cortical area or cell type from another.
Understanding the neuronal circuits that underly face processing requires relating the genetic identity of different
face areas and individual face cells to their specific functions. In this project, we propose pilot work to generate
a first-ever, cell-type-specific, functional map of face areas in the primate brain. We will use the common
marmoset, a New World primate model amenable to genetic manipulation and with a lissencephalic brain
accessible for optical imaging. We will leverage newly generated atlases of molecular-defined cell types of the
marmoset brain that will guide the selection of gene panels to survey face areas. We have established methods
that combine functional imaging with post-hoc spatial transcriptomics that allows for dense surveys of population
activity and their subsequent cell-type identification. In Aim 1, we will combine optical intrinsic imaging with
sequencing-based spatial transcriptomics to determine whether the topological arrangement of face patches can
be defined by its molecular architecture. In Aim 2, we will combine population two-photon calcium imaging with
imaging-based spatial transcriptomics to determine whether face-selective cells are defined by specific molecular
cell types. This pilot study will lay the groundwork for the genetic dissection of cortical circuits underlying primate
face processing. This will allow us to unravel the circuit-level computations that give rise to facial perception and
how such processes are altered in neurodevelopmental and neurodegenerative disorders that disrupt social
cognition.

Public health relevance
PROJECT NARRATIVE Understanding how face perception is a fundamental process of social cognition. Deficits in face processing are a hallmark of several neuropsychiatric disorders, including autism spectrum disorders and prosopagnosia. This research project will provide a link between the cell types and genes that define the neurons underlying face processing which will enable targeted treatment of disorders affecting this aspect of visual perception.